Postdoctoral Reearch Training and Education in Geroscience (10 of 11) RL9

The proposed program in research training and education is designed to prepare NRSA and non-NRSA postdoctoral trainees for careers in the emerging field of "geroscience" [unreadable] the integrated, interdisciplinary study of aging and age-related diseases. The Buck Institute for Age Research is uniquely positioned to provide broad-based training and education in this field, and thereby ready its participants to make important contributions to our understanding of the biology of aging and its attendant health consequences. Some key assets of the Buck Institute in this regard are its strong institutional focus on aging research, highly interdisciplinary approach to research problems, advanced technologic infrastructure, outstanding faculty with diverse scientific and clinical expertise and prior teaching experience, and the unsurpassed regional research environment and facilities of the San Francisco Bay Area. The Buck Institute has devoted major effort and resources to the training of junior scientists, especially postdoctoral fellows, in aging research. In addition to working in the laboratories of Buck Institute faculty members, these fellows have access to didactic courses designed to better equip them for independent careers in aging research in academic or biotechnology settings, as well as practical instruction in career-development skills including research ethics, scientific presentations, grant writing and teaching. This postdoctoral training program's Specific Aims are to: AIM 1. Provide postdoctoral trainees with interdisciplinary laboratory experience in geroscience [unreadable] the integrated study of aging and age-related diseases. AIM 2. Provide postdoctoral trainees with didactic teaching in disciplines inherent to geroscience and practical instruction that will assist in their scientific career development.